LOCAL AND SYSTEMIC REGULATION OF BONE DEVELOPMENT

The objective of this project is to investigate local and systemic control of bone development by extracellular matrix components. Projects currently under study are: 1) purification of bone inductive proteins from human and bovine bone; 2) specificity of osteogenin action and its modulation by other growth factors; 3) transforming growth factors and bone differentiation; 4) role of collagenous substratum in bone induction; 5) influence of aluminum on mineralization during matrix-induced bone development, and 6) influence of demineralized dentin matrix on transformation of muscle into cartilage.